Developing and Testing Warning Labels for Retail Cannabis Products

PROJECT ABSTRACT
Despite the legalization of retail cannabis (i.e., non-medical, “recreational”) in multiple states, there are still
no federal regulations for warnings on cannabis products in the U.S. This is troubling because states that legalize
cannabis report increased calls to poison control centers, and cannabis consumption has been associated with
cognitive impairment, deadly lung disease, and respiratory problems. At the same time, cannabis has therapeutic
benefits, including reduced spasticity for multiple sclerosis patients. The fact that cannabis has adverse and
therapeutic outcomes has contributed to an environment where substantial proportions of U.S. consumers both
over- and under-estimate the health risks of cannabis. This highlights the need for clear, effective labeling
regulations to ensure accurate risk perceptions. Despite evidence of the efficacy of health warning attributes
(e.g., adding pictures to text), there is limited data on how such warning attributes influence cannabis consumers
in the U.S. This proposal will inform how cannabis warning-label characteristics influence cannabis consumers’
(i.e., past 30-day use) attitudes and beliefs, intentions, and problematic cannabis use behaviors by
accomplishing the following specific aims: Aim 1: Assess consumer perceptions about draft cannabis warning
labels through focus groups with adult cannabis consumers (21+) from legal retail states; Aim 2: Determine how
attributes of updated cannabis warning labels affect cannabis consumers’ (21+ from retail states) emotions and
perceived risk using a discrete choice experiment (DCE); Aim 3: Use a randomized clinical trial (RCT) to test
enhanced warning labels against the existing product labels to determine how exposure influences cannabis
consumers’ (21+ from retail states) label reactions (emotion and reactance), attitudes and beliefs (perceived
risks and health beliefs about cannabis), and intentions for problematic use (e.g., driving after cannabis
consumption) immediately after exposure (Session 1). At 2-week follow-up (Session 2), we will measure
message recall and cannabis-use behaviors in the last 2 weeks (i.e., interpersonal conversations about
cannabis, cannabis use, money spent on cannabis, quitting attempts, and problematic use), and behavioral
intentions (motivation to quit cannabis in 6 months). This innovative proposal includes training activities to ensure
that Dr. Massey achieves the following five career goals: 1) Develop expertise in psychological and biological
mechanisms of addiction; 2) Receive hands-on training for the development of cannabis warning labels; 3) Learn
advanced research methods for warning label research with DCEs; 4) Acquire advanced training in RCTs; and
5) Create a sustainable line of research for future R01 submissions. The mentorship team includes experts in
developing and testing warning labels (Hammond, Thrasher, Popova), substance use research (Hammond,
Froeliger), cannabis policy (Hammond), mixed methods (Popova, Rodgers, Thrasher), and design of DCEs and
RCTs to test consumer warnings (entire team). The proposed mentorship, training, and research activities would
prepare Dr. Massey for an independent research career with a sustainable substance-use research program.

Public health relevance
NARRATIVE Despite the legalization of cannabis in multiple states (it is only fully illegal in 6), there are still no federal regulations for health warnings on cannabis products in the U.S. The fact that cannabis has adverse and therapeutic outcomes has contributed to an environment where substantial proportions of U.S. consumers both over- and under-estimate the health risks of cannabis. This project will assess adult cannabis consumers’ reactions to draft warning labels, experimentally determine how attributes of cannabis warning labels affect consumers’ emotions and perceived risks, and then develop and test our enhanced warning labels against existing labels to determine how label exposure influences perceived risk, health beliefs, and higher-risk cannabis use.